Multidisciplinary Training in Digestive Diseases

PROJECT SUMMARY/ABSTRACT
In this renewal application of an established (42 years), successful multidisciplinary training program in
Digestive Diseases, we will continue to train qualified postdoctoral individuals (M.D., and/or Ph.D.) for academic
careers in digestive diseases. Our interdisciplinary, full time faculty of 36 scientists supports two tracks for
potential trainees: i) basic/disease oriented research; and ii) patient-oriented research. The basic/disease
oriented track remains one of long-standing excellence with training opportunities in mucosal immunology, cell
biology, enteric neurosciences, liver pathobiology, and new opportunities organized around regenerative
medicine/stem cells and transcription/epigenetics. Training in this track is strongly supported through
interactions with the NIH funded Mayo Comprehensive Cancer Center, Basic Science Departments at Mayo
Clinic, and the NIH P30 Digestive Disease Center grant. The patient-oriented track, which is educationally
buttressed through the Mayo Center for Translational Science Activities (CTSA), maintains training opportunities
in human genetics/epidemiology, obesity/nutrition, human imaging/physiology, and the science of healthcare
delivery/comparative effectiveness, the latter being a new area of institutional focus. We continue to request
support for 5 postdoctoral trainees/year that are selected through objective and consensus-driven mechanisms
from a talented annual pool of approximately 100 M.D., PhD, or M.D./PhD candidates derived from a variety of
clinical and basic disciplines. The overall success of the program continues to be outstanding with 85% of
trainees from the most recently completed 10-year cohort (n=24) entering into an academic medicine staff
appointment and a funding portfolio from this cohort that includes 13 new federal grants (4 K series, 5 R series,
4 P30 pilots). Understanding the positive impact of diversity on the training environment and outcomes, we are
currently experiencing our most diverse chapter in our history. Over the current reporting period 50% of the
trainees are women and 32% of appointments were filled with applicants of Diverse Backgrounds. Institutional
support also continues to be strong and well documented. Thus, this highly established training program
remains creative, innovative, and dynamic, thereby continuing to be highly successful in achieving its goal of
training individuals for academic careers in gastroenterology and hepatology.

Public health relevance
PROJECT NARRATIVE Developing the next generation of physicians and scientists is essential for the successful pursuit of new treatments for digestive diseases; this training grant will assist in achieving this goal.